CCOPSYS Integration

DCP and DCTD (e.g., CTEP) have developed separate web-based systems to provide member sites with a limited ability to manage and maintain institution and/or person roster information. The DCP system is in use for the Community Clinical Oncology Program (CCOP) funded organizations to add institutions and investigators to their rosters. This information is shared with the research bases, but its used by the research bases is inconsistent, resulting in CCOP Administrators and staff requesting the same roster update from multiple organizations.

Public health relevance
Public Health Relevance: 1. Process Efficiency Across NCI: There are several key processes that DCP, CTEP, DCCPS, DCP-CCOP and the cooperative group program encounters in their daily operations, such as roster updates,. Automating such processes enables NCI to avoid new hires that would otherwise be required to manage these processes, and redeploy staff to higher-value activities to help innovate and grow. 2. Dramatically Improved Visibility: Real-time visibility is important in making timely informed decisions. When information can be accessed instantly from almost anywhere, without wasting resources on data extraction and tying data from different sources together, NCI or it colleagues are better informed and can make more accurate, faster decisions. 3. Significant Time and Cost Savings for out-years: With IT no longer having to procure, install, and maintain multiple systems as well as the various integrations between them, a significant reduction in operational costs can be realized while IT time can be spent improving the program operations. 4. User-Driven Innovation: Because process changes can be implemented quickly, everyday business users are able to apply their functional expertise to tailor processes and applications in a way that improves performance.